Proteomics Core

P20 Proteomics Core

Modified Project Summary/Abstract Section

PROJECT SUMMARY/ABSTRACT

The INBRE-supported VBRN Proteomics Facility, which was incepted in 2006, provides expertise and service to network clients for state-of-the-art proteomic analyses. We are the only proteomics facility in the Northern New England Region (VT, NH, ME) that provides users with a comprehensive array of mass spectrometry-based technologies, ranging from routine protein identification, analysis of protein interaction, and post-translational modifications to large-scale quantitative proteomics using stable isotopes (e.g., tandem mass tags). With our state-of-the-art instrumentation, proteomics methods have been established over the years to help users from 15 States (11 States in INBRE 4 including 6 IDeA States), resulting in more than 200 publications (41 papers in the first 4 years of INBRE 4), and supporting many grant awards (30 NIH grants including 13 R01 in INBRE 4). The facility continues to build its regional impact through developing new expertise and services. In INBRE 4, we have started collaborating with users to establish new proteomics methods and will make these workflows available to users in the region and other IDeA states during INBRE 5. The facility supports the education and training of students in developing contemporary proteomics skills that will prepare them for graduate-level research training or entry into the biomedical workforce. Since 2006, more than 500 undergraduates have benefited from lectures, hands-on data analysis, and facility tours. In INBRE 5, the facility will continue helping course instructors at the University of Vermont (UVM) and our baccalaureate partner institutions to incorporate proteomics components into their courses. The facility will also expand its successful internship program in INBRE 5. Undergraduates will learn working knowledge of proteomics by participating in investigators’ research projects and the facility’s method development efforts. The facility implemented an income/expense (I/E) model in INBRE 4 year 2. With VBRN support and UVM subsidy, the facility generated a net revenue for the first and second years of I/E (INBRE 4, year 2 and 3), and a cost-neutral is projected for year 3 of I/E and onwards (INBRE 4, year 4). In INBRE 5, efficiencies will be further achieved via cohesive business plans, coordinated efforts for instrument acquisition, centralized inventory/ordering, and user surveys through the Center for Biomedical Shared Resources.